Novel Mechanisms of Exercise Training Effects on Glucose Homeostasis

PROJECT SUMMARY/ABSTRACT
While it has long been established that exercise training can have profound effects on systemic glucose
homeostasis and skeletal muscle metabolism, more recent research has demonstrated that adipose tissues
also play an important role in mediating the benefits of exercise on metabolic health. Studies supported by this
award have shown that subcutaneous white adipose tissue (scWAT), the adipose tissue located beneath the
skin, undergoes profound changes in gene and protein expression, structural architecture, and adipokine
profile in response to exercise training, adaptations that play a strategic role in regulating systemic exercise-
facilitated metabolic benefits. The signaling and intracellular mechanisms that control these important changes
in scWAT phenotype and function are not known, but our preliminary data demonstrate that lactate and
glycogen, two factors typically associated with skeletal muscle metabolism in response to exercise, also play
fundamental roles in regulating exercise training effects on scWAT. In Specific Aim 1 lactate signaling through
the G-protein receptor 81 (GPR81) and glycogen metabolism will be investigated as essential mediators of
exercise training-induced adaptations to scWAT phenotype, and in turn, whole body systemic metabolism.
Numerous approaches including genetically modified mouse models, physiological assessments, proteomics,
RNAseq, and lipidomics will be used for this Aim. Specific Aims 2 and 3 will focus on visceral white adipose
tissue (vWAT), the adipose depot that surrounds the internal organs under conditions of fuel over-abundance.
While vWAT has been less studied in the context of molecular adaptations to training, our recently published
multi-omics project investigating key metabolic tissues led to the discovery that under obese conditions,
exercise training induces more profound cellular composition and transcriptomic changes in vWAT compared
to scWAT. We also found that obesity and training significantly impact crosstalk between immune cells and
adipose stem cells (ASCs) in vWAT. Given that exercise is a potent epigenetic modulator, we hypothesize
that exercise training reverses the unfavorable responses to obesity by rewiring of the underlying epigenome
of vWAT. In Specific Aim 2, single cell level open chromatin accessibility and lncRNA expression profiling in vWAT
will be done to determine the epigenetic mechanisms mediating the effects of exercise training and obesity. In Aim
3, exercise training- and obesity-induced immune cell-ASC crosstalk using in vitro and in vivo models will be studied.
This will include a focus on the putative interaction between amphiregulin, produced by type 2 innate lymphoid
cells (ILC2s) with epidermal growth factor receptor of the ASCs, as this was the most striking interaction
predicted by our in-silico single cell analysis. To complement our expertise in exercise science, adipose tissue
biology, cell signaling, metabolism, and in vivo models, studies will be performed in collaboration with world
renown experts in computational biology and immunology. Thus, these studies will generate high quality
scientific discoveries with high potential for clinical impact for the treatment of obesity and type 2 diabetes.

Public health relevance
PROJECT NARRATIVE Diabetes is a major public health problem and exercise has an essential role in the management and prevention of this disease. The goal of this research is to find out how exercise training causes fundamental changes to adipose tissue that signal the body to improve overall metabolism, including lowering blood sugar and lipid levels and enhancing function of other tissues such as liver, muscle and kidney. These studies will lead to a better fundamental understanding of the beneficial effects of exercise on health and may help to identify therapies for diabetes.